Self-Test Strategies and Linkage Incentives to Improve ART and PrEP Uptake in Men

Project Summary
Ending the AIDS epidemic in sub-Saharan will require further engagement of men in HIV testing, prevention,
and treatment, a challenging task given that nearly 50% of HIV-positive men in many countries are unaware of
their HIV status and men have lower uptake of HIV antiretroviral therapy (ART) and pre-exposure prophylaxis
(PrEP). This study focuses on a highly mobile population of men – fishermen – in Kenya’s Lake Victoria
shoreline communities, where HIV incidence rates are extremely high. Two recent innovations – HIV self-
testing (HIVST) and social network-based interventions – hold promise for overcoming barriers to HIV testing
and linkage to services for both HIV-positive and HIV-negative men. This study seeks to determine if an HIV
status-neutral, social network-based approach, along with low-cost incentives, can promote HIV testing,
linkage to care and prevention, and better health outcomes in men. It will pursue three aims:
Aim 1: Determine whether providing HIV self-tests to network-central men for distribution to other men
in their close social networks increases men’s HIV testing uptake. We will conduct social network
mapping in study communities in Siaya Country, Kenya to identify distinct close social networks of men.
We will then randomize these social networks to intervention and control groups. Network-central, highly-
connected men in each network will be recruited as “promoters”, and receive HIVST training. Promoters in
networks assigned to the intervention will then receive self-tests for distribution to men in their networks.
Promoters in networks assigned to the control will instead distribute vouchers for free self-tests at nearby
health clinics. We hypothesize higher HIV testing among men in networks that receive the intervention.
Aim 2: Determine whether network-central promoters and small incentives can increase ART and PrEP
uptake among men. We will test whether network-central promoters can enhance linkage to ART and PrEP
after self-testing, thereby addressing a key limitation of HIVST. Promoters in the Aim 1 intervention group
will be asked to distribute information and transport vouchers for ART or PrEP to men in their networks. Our
primary hypothesis is that the intervention will result in higher rates of linkage to ART or PrEP (confirmatory
testing and ART referral for positives, and PrEP screening for negatives). We also hypothesize higher ART
and PrEP uptake within 3 months among men in social networks assigned to the intervention group.
Aim 3: Test the impact of interventions on ART or PrEP retention and adherence. We will measure 6-
and 12-month VL and tenofovir levels, using a recently-developed low-cost, point-of-care PrEP adherence
urine immunoassay. Across all aims, we will use qualitative and mixed methods to identify the pathways
of intervention action, and understand how social networks and incentives affect testing and ART and PrEP
uptake and retention. This study promises high scientific and public health impact, by testing new
approaches to improve the prevention and care cascades in high-risk, mobile men in high priority settings.

Public health relevance
Project Narrative This study aims to identify strategies needed to close gaps in the HIV care and prevention cascades in high priority populations and settings in sub-Saharan Africa. These gaps are most pronounced in men, who are less likely than women to test for HIV and seek HIV treatment or prevention services, and in high HIV incidence settings such as western Kenya. We will harness the power of peer influence within men’s close social networks and leverage new technologies such as HIV self-tests and point-of-care PrEP adherence assays to increase men’s HIV testing rates and strengthen men’s ongoing engagement in HIV care and prevention.